Bone metabolism in adolescents undergoing GLP-1 receptor agonist therapy

Abstract
Obesity is now epidemic, and as a consequence, the use of weight loss medications and surgery to manage
obesity is increasing in both adults and adolescents. Metabolic and bariatric surgery (MBS) effectively enables
sustained weight loss. However, our data in adolescents and young adults indicate that it causes marked loss of
bone density, structure, and strength estimates. This is particularly alarming during adolescence, a time of rapid
bone accrual towards attainment of peak bone mass, a key determinant of fracture risk across the lifespan. With
the increasing use of weight loss medications, particularly glucagon-like-peptide 1 receptor agonists (GLP-1 RA),
in adolescents, it is essential to determine whether weight loss following use of these medications is associated
with similar detrimental effects on bone accrual. Interestingly, our preliminary data in adults and adolescents
indicate preservation of skeletal health despite significant weight loss following use of GLP-1 RA. GLP-1 RAs
have direct bone anabolic effects, as demonstrated in both rodent and human studies, and also anti-resorptive
effects. Thus, a GLP-1 RA might mitigate the deleterious effects of weight loss on skeletal health through a direct
impact on bone formation and resorption. Data from the literature are conflicting with one study reporting no
change or improved bone outcomes following use of semaglutide (a commonly used GLP-1 RA) in adults with
obesity, while another reported deterioration in bone outcomes following semaglutide use. Whether GLP-1 RA
use preserves critical bone anabolic activity during adolescence merits investigation and is the focus of our
proposal. If our hypotheses prove correct and use of GLP-1 RAs preserves bone accrual in youth with obesity,
the results of this study will be paradigm shifting in the management of obesity in youth, favoring GLP-1 RA
treatment over MBS following lifestyle management. Our overall hypothesis is that despite marked weight
loss in adolescents and young adults with obesity receiving semaglutide (commonly used and FDA
approved for use in children 12 and older) over 2 years, study participants will demonstrate preservation of
areal and volumetric BMD, bone geometry, structure and estimated strength, and improvements in
estimated fracture risk. In Aim 1, we will determine to what extent semaglutide alters bone density, geometry,
structure, and strength, and load-to-strength ratio prospectively over 2 years in youth ages 12-21 years with
obesity compared to controls of similar weight followed with lifestyle management. In Aim 2, we will investigate
whether alterations in bone turnover markers explain how semaglutide impacts skeletal health. Our multi-center
study will provide novel data needed to establish whether use of a GLP-1 RA prevents the impairment in skeletal
health observed following MBS in youth. Clarifying these mechanisms will identify optimal weight loss strategies
in youth with obesity following lifestyle intervention.

Public health relevance
Narrative We will assess the impact of semaglutide, a commonly used glucagon like peptide-1 receptor agonist, on bone outcomes in youth with obesity. Semaglutide typically causes significant weight loss in patients with obesity. Despite this expected weight loss following use of semaglutide over a 24-month period, we expect bone outcomes to remain stable because of the direct effects of glucagon like peptide on bone.